USIDNET: A resource for clinical immunologists

ABSTRACT
The United States Immunodeficiency Network (USIDNET) has been continuously funded as a resource for
Clinical Immunologists since 1992, evolving from single diagnosis registries to a panel of research resources
including a robust diverse patient registry with quality of life, laboratory, and clinical features; patient cell lines,
and a variety of educational efforts. In 2017, the registry converted the data to SNOMED and LOINC terms,
ushering in an era characterized by data standards and interoperability. The registry currently holds complex
phenotype data on over 5000 patients with over 3000 discrete data fields. Genetic information is available on
over 2000 patients. Under a new funding mechanism, USIDNET is poised to further enhance resources both
incorporating and improving the state of genetic diagnostics for Inborn Errors of Immunity. Our central goal is
to serve as a nexus of information on genotype and phenotype. The USIDNET registry will continue to serve a
critical need by defining phenotypes and propelling improved outcomes research with enhanced longitudinal
data. This evolution renders additional technical innovations possible in a manner that will serve community
needs identified through discussion and a survey. This Program has six Aims which all derive from the central
registry effort. The new registry will be anchored by a semi-automated data extraction from participating sites
to maximize data standardization and longitudinal collection. Input of genetic data will be standardized and we
will offer next generation sequencing to patients who otherwise cannot have sequencing, to improve the
richness of genetic data in USIDNET and to nucleate a “matchmaking” effort. The six Aims are interwoven to
support improved data and utilization. In Aim 1, we will improve the registry by developing a protocol for direct
data extraction that can be shared across institutions and instituting a Single IRB to facilitate regulatory
compliance. Aim 2 develops improved guidance for registry utilization, provides statistical support for end
users, and spearheads studies of high impact, defined by the Steering Committee. Aim 3 proposes an
innovative use of data to connect investigators who have similar patients through a specific matchmaking
approach. In Aim 4, we will utilize USIDNET data to augment efforts to enrich immunology HPO terms and
ClinGen entries. In Aim 5, we will galvanize successful dissemination efforts, develop a newsletter with
structured features to improve clarity, and enhance material on our website. In Aim 6, we will formalize
mentoring efforts to strengthen the research skills of the next generation and provide career mentoring. These
resources will provide pivotal information for the Immunology community at a time when the wealth of new
monogenic Inborn Errors of Immunity have made clinical decision making far more complex and uncertain.
This new R24 builds on previous successes defining phenotypes in Inborn Errors of Immunity, improves data
collection, and utilizes the data in new ways to support the community.

Public health relevance
PROJECT NARRATIVE People with an Inborn Error of Immunity live with uncertainly related to the correct diagnosis, their future, and best management for their condition. The purpose of this study is to provide resources to help physicians and patients make critical decisions regarding care. We will build a database of patient health information and use this as a nexus of efforts to improve patient outcomes by serving as a resource for gene-variant-phenotype in Inborn Errors of Immunity.